NONHUMAN PRIMATE MODEL FOR TB VACCINES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Macaques experimentally inoculated with Mycobacterium tuberculosis (M.tb.) show clinical signs of tuberculosis (TB). This project will evaluate novel anti-tuberculosis vaccine formulations for efficacy in rhesus macaques.